Vaccines for human Schistosomiasis japonica

The overall aim of this RO1 application is to identify and evaluate novel candidate antigens for a vaccine against human schistosomiasis japonica. Schistosomiasis, caused by three principle species of dioecious trematodes (flatworms), currently infects over 250 million people world-wide and results in 1.53 million DALYs lost per annum. A recent reassessment of the global burden of schistosomiasis suggests that the actual health burden is 4 to 30 times greater than the previous WHO estimate. These tremendous figures underscore the impact a schistosomiasis vaccine would have on global human health. Although schistosomiasis is effectively treated with Praziquantel (PZQ), rapid reinfection with rebound morbidity precludes effective control based on chemotherapy alone and justifies current efforts to develop vaccines for these parasites. We propose to capitalize on plasma samples and parasitologic data already collected during our previous R- 01 funded studies, to identify novel antigens associated with resistance in humans. In related work in malaria, we have recently developed and validated a whole proteome, differential screening method to identify parasite antigens that are recognized by antibodies in plasma of resistant but not susceptible individuals [5]. These antigens were then validated using high throughput immune profiling of antibody responses and analysis of these responses in the context of resistance to reinfection. These experiments identified RAMA, a novel vaccine candidate for falciparum malaria. We now propose to use this novel, validated method together with plasma and epidemiologic data already collected from our exquisitely well characterized longitudinal treatment-reinfection cohorts to identify and validate vaccine candidates for human schistosomiasis. We will down-select the identified candidates using bioinformatics, tissue- and stage- specific immunolocalization studies, in vitro larval killing assays, and, if necessary, small-scale mouse protection studies. Four of these down-selected candidates will be evaluated for efficacy and safety (including hypersensitivity) in buffalo vaccine trials in Yrs 4 and 5. The outcome of these studies will be a list of validated antigens associated with resistance to reinfection in humans. These data will provide a strong basis to prioritize antigenic targets for additional preclinical safety and efficacy studies in both rodents and large animal models. These data will further the rational development of vaccines that limit reinfection and consequent morbidity and mortality in humans.

Public health relevance
The overall aim of this RO1 application is to identify and evaluate novel candidate antigens for a vaccine against human schistosomiasis japonica. We will use a novel, whole proteome, differential screening method coupled to high throughput immune profiling to identify parasite antigens that are recognized by antibodies in plasma of resistant but not susceptible humans.